MBRS Research Initiative for Scientific Enhancement

DESCRIPTION (provided by applicant): FIU RISE Summary Abstract According to the 2005 Woodrow Wilson Foundation report, "Diversity &the Ph.D.", while African Americans and Hispanics together currently constitute approximately 1/3 of the U.S. citizens in the Ph.D. candidate age range, they only receive 7% of the doctorate degrees. This disparity constitutes a large untapped resource for the scientific research workforce. Mid-decade Census Bureau numbers point to the increasing diversity in the U.S. population. Additionally, as Amri Johnson (The Scientist 2005) notes "...it has become increasingly clear to a growing body of scientist and policy maker that building a diverse pool of scientists and clinical investigators is mission critical in our efforts to reduce health disparities." Accordingly, there are important national considerations for increasing the participation of under-represented minorities in biomedical research. Florida International University (FIU) is an urban, public research university located in Miami, Florida's largest population center. With over 38,000 students (72% underrepresented minority students), "Health" as a mission area, and its stated goal to be one of the nation's top 25 public urban research universities, FIU, through this proposed FIU MBRS RISE Program, provides a significant opportunity to develop more underrepresented minority scientists for biomedical research careers. This multifaceted RISE Program will, through student biomedical research oriented development activities at FIU: 1) build the biomedical research atmosphere in general;2) encourage underrepresented minority students at FIU to view biomedical research as a viable career option;and 3) for those that chose that path, prepare them for success in their biomedical career endeavors. This will be achieved through two initiatives. The Student Research Experience Initiative will provide a selected group of fifteen undergraduate and seventeen graduate students an intense research experience and other training to promote their success as future biomedical research scientists. The Biomedical Research Initiative will provide biomedical research exposure and training to the larger university audience through an annual symposium, development of an advanced technique workshop and a supervised independent biomedical research experience. The proposed FIU program will further the MBRS Program goals of increasing the number of underrepresented minority scientists engaged in biomedical research. FIU RISE Narrative There are important national considerations (including reduction of health disparities) to increasing the participation of under-represented minorities in the biomedical research endeavor. This proposed FIU MBRS RISE Program will further the NIGMS MBRS Program goals of increasing the number of underrepresented minority scientists engaged in biomedical research.